Life at 100.4: An Immersive Social Virtual Reality Education Tool for Adolescent and Young Adult Cancer Patients and Caregivers

ABSTRACT
Nearly 90,000 adolescent and young adult (AYA) patients are diagnosed with cancer each year
in the United States and cancer remains the leading cause of disease-related deaths in this
population. Patients whose families struggle with access to resources or have low health literacy
experience unique challenges that disproportionately negatively impact their outcomes and
ability to adhere to therapy. The most common complication in oncology patients is febrile
neutropenia, a condition marked by fever and a low number of white blood cells that make
patients more susceptible to life-threatening infections. The mortality of untreated febrile
neutropenia is as high as 30%. Factors that impact outcomes in patients with febrile neutropenia
include delay to care and not receiving antibiotics in a timely manner. Reasons for delay to care
include a lack of understanding about the seriousness of febrile neutropenia and difficulty
navigating the healthcare system. Virtual reality can provide a unique method for patient
education, as it has been found to provide better retention of information through role-play and
immersion compared to reading text or listening to lectures. This proposal aims to combat
knowledge gaps surrounding febrile neutropenia through the implementation of a novel,
immersive social VR-based intervention called Life at 100.4. This program will provide critical
education to patients and caregivers to set expectations and develop appropriate management
techniques related to febrile neutropenia during cancer treatment. This work will result in the
development of a critical new tool specific to febrile neutropenia while also serving to establish
VR more broadly as an effective patient and caregiver education tool, particularly for the near
40% of the population with low health literacy.

Public health relevance
NARRATIVE This research proposal utilizes virtual reality to develop an effective, evidence-based, and immersive educational social experience for patients and caregivers to better understand febrile neutropenia, quickly access appropriate medical care, and adapt to accessing that care in different settings. The goal of this project is to provide patients and caregivers with information specific to febrile neutropenia while setting the stage for establishing virtual reality as an effective tool for patient education. By surmounting existing barriers that prevent understanding and accessing healthcare, we can ultimately improve health outcomes for patients everywhere, regardless of health literacy and background.